PRE & POST DOCTORAL TRAINING

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. There are 6-10 graduate students and postdoctoral fellows at any one time using the NCMI's facilities to pursue their Ph.D. thesis work. We also host students and postodocts from other institutions to come collecting data or processing data.